Rhode Island Human Food Rapid Response Teams

Grant Proposal Abstract
Title: Rhode Island’s Maintenance of Human Food Rapid Response Team
Funding Opportunity Number (FOA): RFA-FD-23-019
The Rhode Island Department of Health (RIDOH), Center for Food Protection (CFP) will continue to
maintain the operations of its multi-jurisdictional, multi-disciplinary, Rhode Island Rapid Response
Teams (RI RRT). To do this, RIDOH will coordinate with internal and external partners including, but not
limited to, laboratory, epidemiology, emergency management, the FDA Division Office and the Office of
Partnerships. Incident response and surveillance work conducted by the RI RRT will include foodborne
illness investigations, tracebacks, environmental assessments, sample collection, laboratory analyses,
and recalls. To facilitate long-term improvements and contribute to the national integrated food safety
system, the RI RRT will unify and coordinate emergency response efforts including:
1) Strengthening the link among epidemiology, lab and environmental health/regulatory
components;
2) Improving States' regulatory and surveillance HAF protection programs to include using
Incident Command System (ICS)/National Incident Management System (NIMS) principles
and a Unified Command structure to conduct integrated responses to all-hazards HAF
emergencies, rapidly identifying and removing tainted food from commerce, and conducting
root cause investigations to inform future prevention efforts; and
3) Addressing supporting components, such as training, data sharing, data analysis,
communications, continuous process improvement, and development of best practices and
other resources to support national response capacity/capability development.

Public health relevance
Project Narrative Title: Rhode Island’s Maintenance of Human Food Rapid Response Team Funding Opportunity Number (FOA) : RFA-FD-23-019 This grant will support the efforts to maintain the Rhode Island Rapid Response Teams (RI RRT) to facilitate long-term improvements and innovation to the national integrated food safety system by unifying and coordinating federal/state/local human and animal food (HAF) emergency response efforts including: 1) Strengthening the link among epidemiology, lab and environmental health/regulatory components; 2) Improving States' regulatory and surveillance HAF protection programs to include using Incident Command System (ICS)/National Incident Management System (NIMS) principles and a Unified Command structure to conduct integrated responses to all-hazards HAF emergencies, rapidly identifying and removing tainted food from commerce, and conducting root cause investigations to inform future prevention efforts; and 3) Addressing supporting components, such as training, data sharing, data analysis, communications, continuous process improvement, and development of best practices and other resources to support national response capacity/capability development.